Evaluation of a Remotely-Delivered Behavioral Intervention for Post-Bariatric Surgery Weight Regain

PROJECT SUMMARY/ABSTRACT
The proposed study is designed to evaluate the efficacy of a remotely-delivered, acceptance-based
behavioral intervention (ABTi) for individuals demonstrating weight regain after bariatric surgery by comparing
it to a Control condition. The current study aims to: 1) evaluate ABTi's efficacy on weight outcomes compared
to Control; 2) evaluate ABTi's efficacy on secondary outcomes including improvements in eating behaviors,
physical activity, and medical conditions compared to Control; 3) test proposed mechanisms of action,
including evaluating a) if changes in hypothesized active ingredients in ABTi mediate differences in weight
outcomes between conditions and b) if the association between eating behavior and subjective internal states
(i.e., hunger, cravings, urges, negative affect) will weaken in ABTi compared to Control. Patients 6 to 48
months out from surgery who have regained >5% of their weight will be randomized to ABTi or Control
(n=200). Assessments willbe conducted at baseline, 3, 6 (end of active treatment), and 12 months (follow up)
after enrollment. Developing innovative interventions to reverse postoperative weight regain is crucial to
maintain the health benefits of surgery in this growing population of patients not experiencing optimal
postoperative results.

Public health relevance
PROJECT NARRATIVE Bariatric surgery is the most effective obesity treatment available, producing large and durable weight losses for a majority of patients. Unfortunately, 20-30% of patients who undergo bariatric surgery experiencer significant weight regain and recurrence of weight-related comorbidities. The proposed study will test the efficacy of a novel psychotherapeutic intervention, delivered remotely, to reverse weight regain and maintain the health benefits of bariatric surgery.